Precision MRI with Protein Contrast Agent for Noninvasive Detection of Lung Fibrosis

Summary
Lung diseases, such as interstitial lung diseases, including idiopathic pulmonary fibrosis (IPF), chronic
obstructive pulmonary disease (COPD), and acute viral infection, are major leading causes of death worldwide.
IPF is characterized by increased extracellular matrix (ECM) deposition, especially type I collagen, within the
lung, causing irreversible lung damage. While high-resolution computed tomography (HRCT) is commonly used
to diagnose IPF, this method can produce large inter-observer variation and error (up to 50%) and cannot detect
early-stage lung fibrosis due to poor soft tissue contrast. A surgical lung biopsy is often required to confirm the
diagnosis for patients with suspected IPF. However, this is very risky due to comorbidities and physical
impairments. HRCT and other available diagnostic methods provide little information about heterogeneous
fibrosis related to disease activity, progression, and regression. There is a pressing unmet medical need to
develop noninvasive imaging methodologies and contrast agents to detect early stages of lung fibrosis, and to
stage fibrosis severity and heterogeneous expression of collagen. The main objectives of this Phase II
application will provide necessary results for transition to clinical application for non-invasive longitudinal early
diagnosis and staging of lung fibrosis with disease activity by pMRI. Aim 1 is to analyze toxicology and metal
toxicity of ProCA32.collagen in healthy and lung fibrosis mice. We will complete single and repeating dose
studies to verify that INL-101 is not toxic using established IPF animal models including reversible and
irreversible fibrosis models. We will also determine minimal effective dose of INL-101 for determining lung
fibrosis. Aim 2 is to execute the designed TOX/PK safe profile studies for IND application and prepare human
imaging. We will optimize injection routes for in vivo imaging for IND application. This transformative platform
and proprietary methodology will have strong impact in IPF patient stratification for effective treatment and
reduction of mortality by distinguishing IPF patients who are experiencing rapid progression from those who are
stable based on features of reversible and irreversible fibrosis.

Public health relevance
Narratives Developed INL-101 with pMRI will provide accurate and early detection of IPF patients without invasive biopsy and harmful radiation. This transformative platform and proprietary methodology will have strong impact in IPF patient stratification for effective treatment and reduction of mortality by distinguishing IPF patients who are experiencing rapid progression from those who are stable based on features of reversible and irreversible fibrosis. It will enable sensitive detection of treatment responses and facilitate drug discovery by largely reducing errors associated with current end-of point-segmented analysis and mechanism. understanding the fibrosis molecular